Hematopoietic stem cell dysfunction in traumatic brain injury and Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Traumatic brain injury (TBI) is the greatest environmental risk factor for Alzheimer’s disease (AD). Although both
neurological conditions share many of the same pathological hallmarks including neurodegeneration, the
underlying mechanisms that establish this relationship between TBI and AD are not well understood. Acute TBI
transitions into chronic TBI, which is characterized by progressive neurodegeneration. The pathophysiologic
events associated with the transition of acute TBI into a chronic neurodegenerative condition can last for months,
years, or even a lifetime and are also thought to be associated with the pathogenesis of AD after TBI.
Investigating the mechanistic link between acute TBI, chronic TBI, and AD is important as there are currently no
therapeutic strategies to protect patients.
My proposed interdisciplinary project aims to address this knowledge gap by assessing the interplay between
TBI, hematopoietic stem cell (HSC) dysfunction, chronic neurodegeneration, and AD. Specifically, I am testing
the novel hypothesis that acute TBI induces changes to HSCs that in turn play a role in impairing the immune
system and propagating chronic neurodegeneration after TBI, and that these TBI-induced alterations are related
to the increased risk of AD after TBI. HSCs generate the entire spectrum of blood and immune cells, and my
preliminary studies thus far indicate that TBI induces major changes to HSCs, including impaired HSC function,
disrupted blood cell counts, and elevated inflammatory markers.
This study employs a clinically relevant model of TBI, cytometric analyses, and immunohistochemical
approaches to generate a deeper understanding of hematopoietic dysfunction in TBI and AD and the implications
of this dysfunction on the immune system and chronic neurodegeneration. Furthermore, this proposal is tailored
for a physician-scientist in training as it investigates the underlying mechanisms by which acute TBI transitions
into a chronic neurodegenerative condition, with implications for novel therapeutic targets for reducing
neurodegeneration after TBI and protecting TBI patients from developing AD.

Public health relevance
PROJECT NARRATIVE Acute traumatic brain injury (TBI) is causally linked to chronic neurodegeneration and is the leading environmental risk factor for Alzheimer’s disease (AD), yet the reasons why are not understood. In this study, I will investigate the role of hematopoietic stem cell (HSC) dysfunction in mediating the transition from acute TBI to chronic neurodegeneration, and will examine HSC dysfunction in AD and TBI-accelerated AD. Through this research, I aim to contribute to our understanding of the pathophysiology of these neurodegenerative diseases and guide future treatments by unveiling novel therapeutic targets to counteract progressive neurodegeneration.